CONTRACTILITY OF SKELETAL AND SMOOTH MUSCLE

In FY91 our study of the myosin crossbridge interaction with actin in muscle fibers focused mainly on the strongly-binding crossbridge interaction. I derived a quantitative model of that interaction and tested the predictions of the model by studying the effect of ionic strength on the magnesium pyrophosphate crossbridge. It was found that increasing ionic strength from moderate values (-100 mM to high values (-200 mM) has three significant effects. It cause a big decrease in the half time for the force decay after a small stretch, it causes a significant decrease in the sigmoidicity of the magnesium pyrophosphate concentration dependence of the apparent rate constant of force decay after a small stretch, and it causes a big decrease in the range of rate constants necessary to describe the multiexponential force decay. It caused the last of these by causing a much larger increase in the slowest rate constants of the decay than in the fastest rate constants. The results offer strong support for our proposed model of the actin - strongly-binding crossbridge interaction. In smooth muscle we examined the relationship between myosin light chain phosphorylation and force during atrial natriuretic factor (ANF) induced relaxation. Unlike the situation for the onset of contraction, the two do no correlate closely. When ANF relaxes a KC1-induced contraction, a 50% reduction in myosin light chain phosphorylation is accompanied by only a 30% reduction in force. When ANF relaxes a 10-& M acetylcholine contraction, there is no detectable change in myosin light chain phosphorylation but a 50% decrease in force. There is no explanation for these findings at present, especially since we found that ANF applied to a relaxed fiber produces no change in either force or myosin light chain phosphorylation.